Multi-scale, model-driven exploration of sub-generational gene expression in bacteria: individual consequences, population benefits

Research Summary/Abstract
Our goal is to decipher how a molecular-level event or property can create heterogeneous behavior within a
population, and how this heterogeneity leads to advantages for the population as a whole that are not available
to individual members. We propose to determine how sub-generational gene expression - not only of individual
genes, but also of entire operons containing multiple genes with coordinated functions - creates mixed
populations that are more fit to respond to various environmental cues. This proposal, which deeply integrates
computational modeling and experimental measurement, arose out of our efforts in “whole-cell” modeling of E.
coli, which were reported in Science earlier this year. The E. coli model has predicted a number of surprising
behaviors; most relevant is the finding that a clear majority of the genes in E. coli are transcribed at a rate of
less than once per cell cycle - a phenomenon we call “sub-generational gene expression”. Such expression
can have negative consequences for individual bacteria, but benefits the bacterial population as a whole.
Because bacteria are unable to reliably anticipate future conditions, the population must always be prepared
for any environmental change - but no single bacterium is able to express all of the genes required to respond
to any environment at sufficient levels. Instead, our working hypothesis is that the population is heterogeneous,
comprised of individual members who are each prepared for a small number of possible environments. Thus,
while no single cell is ready for all environments, as a whole the population is prepared for most eventualities.
The colony is thus dominated by individuals, emerging stochastically via expression of sub-generationally
expressed genes, who are the most fit to survive at any given moment. Our groups combine expertise in both
whole-cell and agent-based models, and have been working towards whole-cell population simulations, in
which hundreds or thousands of cells each run an instantiation of the E. coli model. Our Aims are to: (1)
confirm that model-predicted genes are expressed sub-generationally; (2) computationally predict and
experimentally determine the effect of operon structure on sub-generational expression of functionally related
gene pairs; and (3) computationally predict and experimentally determine the phenotypic heterogeneity created
by operon separation in cell populations. The most impactful and pioneering aspects of our proposal are that
we will uncover a fundamental new role for operon structure in prokaryotic gene regulation; that we will
produce an expanded whole-cell model of previously unseen complexity, as well as highly innovative new
modeling technology; and finally, that this work will be the first to utilize a novel multi-scale simulation platform
that combines whole-cell models with agent-based models, including the most exciting experimental
demonstration of whole-cell and whole-colony modeling’s major potential: predicting large-scale emergent
properties to generate insights into complex cellular behaviors.

Public health relevance
Research Narrative We are trying to learn the fundamental principles which govern how different bacteria in a population respond to changes in their environment, such as treatment with an antibiotic. Rather than a population in which all bacteria are prepared for any environmental change, we hypothesize that each individual in the population is prepared for certain environments - and that their preparation changes randomly over time depending on the expression of their genes. Combining cutting-edge experimental and computer modeling techniques, our goal is to demonstrate that this phenomenon exists within individual bacteria, and show how it impacts the population as a whole.